Statistical Methods for RNA-seq Data Analysis

DESCRIPTION (provided by applicant): Gene expression data produced from expression microarrays have not only greatly improved our understanding of cell biology, but also provided invaluable resources to guide the diagnosis and treatment of human diseases. However, the pace of incorporating gene expression signatures into medical practice has been relatively slow. This is mainly due to the limitations of gene expression microarrays and the natural variation of gene expression across tissues or developmental stages. This research project aims to overcome these limitations by joint study of germline DNA polymorphisms and allele-specific expression (ASE) obtained from RNA-seq data. Since germline DNA polymorphisms are stable across tissues and developmental stages, inclusion of DNA information will help us establish more reliable biomarkers for patients' clinical care. More specifically, we will study the genetic basis of ASE in both normal and tumor tissues, dissect genetic and parent-of-origin effects on ASE in human cell lines, and identify genes that escape X inactivation in both mouse reciprocal cross and human cell lines.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to develop statistical methods and software for RNA-seq data analysis, with specific aims on dissecting the genetic basis of allele-specific expression (ASE), quantitative assessment of autosomal imprinting in humans, as well as the genetically controlled measurement of escape from X-inactivation in mouse and human. The deliverables of this project will help biomedical researchers to harvest the huge amount of knowledge accumulated in DNA variations and RNA-seq data and translate them into strategies of personalized disease prevention and treatment.